RNA post-transcriptional modifications as possible communication hubs between substances of abuse and HIV-1 replication processes

Drug abuse represents an aggravating factor in the treatment of HIV/AIDS, which is associated with
higher viral load, faster disease progression, and enhanced transmission. Understanding the
mechanisms of these potentiating effects at the molecular level could lead to significant changes in the
administration of current anti-retroviral treatments and the discovery of new therapeutic targets. Recent
findings on the activity of N6-methyladenosine (m6A) in HIV-1 replication and its accumulation in cocaine-
treated cells suggest that RNA post-transcriptional modification (PTM) may represent a key component
of extensive communications between drug and RNA processes. In addition to m6A, the implementation
of a comprehensive analytical approach based on mass spectrometry (MS) allowed us to identify
numerous other PTMs on viral RNA isolated from infected cells and virions. Their striking diversity and
abundance support the proposal’s hypothesis that RNA PTMs may mediate virus-host communications
by modulating essential molecular interactions, which can be influenced by neuromodulators intracellular
signaling. Our highly innovative approach will allow us to test this hypothesis by identifying RNA
processes that are directly affected by the presence of PTMs, determining the effects of dopamine and
GABA signal transduction on PTM expression, and finally recognizing overlaps between the respective
pathways, which will reveal possible crosstalk mechanisms between intracellular signaling and viral
infection. To this effect, we will perform silencing of PTM enzymes and key regulatory genes to retrace
their control networks, while simultaneously monitoring the PTM landscape and essential indicators of
virus and cell fitness. We will determine the variations of PTM landscapes in the absence and presence
of dopamine and GABA, while simultaneously monitoring the effects on prominent RNA processing
infrastructure. We will then probe the PTMs that displayed the most significant variations during both
infection and neuromodulator treatment. The fact that the HIV-1 genome does not code for any known
biogenetic enzyme implies that host enzymes must be responsible for the detected viral PTMs, thus
placing them under the control of key intracellular signaling. Modification may represent adaptation to the
host’s metabolic infrastructure, which enables the viral RNA to evade surveillance and elimination by the
host’s defenses. Therefore, it is possible to envision that this putative adaptation mechanism could be
affected by neuromodulator signaling pathways. This project will look for evidence and will establish the
framework necessary to guide in-depth mechanistic investigations. The transformative impact of the
proposed activities will be substantiated by the ability to test this hypothesis in comprehensive fashion,
expose the influence of PTMs on prominent RNA processes, identify their possible regulatory
mechanisms, and understand the significance of their biogenetic enzymes in viral lifecycle and fitness.

Public health relevance
Project narrative Drug abuse represents an aggravating factor in the treatment of HIV/AIDS, which is associated with higher viral load, faster disease progression, and enhanced transmission. We have discovered unique markers on cellular and HIV-1 RNA consisting of post-transcriptional modifications (PTMs), which are anticipated to play essential roles in mediating virus-host interactions. This project will assess the type and distribution of these viral PTMs, probe their functional impact on viral fitness, and determine the effects of dopamine and GABA intracellular pathways on their biogenesis. The overarching goal is the identification of possible crosstalk between PTM regulation, viral replication, and signal transduction of neuromodulators that play key roles in the reward system involved in drug addiction. Understanding these mechanisms at the molecular level could lead to significant changes in the administration of current anti-retroviral treatments and the discovery of new therapeutic targets.